Regulation of metastatic progression by an endothelial-derived factor

We have previously identified sets of tissue-specific microRNAs that regulate metastatic progression by distinct
cancer types. In both breast cancer and melanoma, such metastasis regulating miRNA pathways enable
cancer cells to avidly recruit endothelial cells into the primary tumor site (Png et al., Nature, 2011; Pencheva et
al., Cell, 2012). A key unknown in the field has been the signal(s) that are provided by such recruited
endothelial cells that impact metastatic progression. We have used an innovative unbiased approach wherein
ribosomes of tumor endothelial cells are genetically marked with an affinity tag. This enables purification of
tumor endothelial ribosomes along with their associated transcripts, which then undergo next-generation
sequencing. This allowed us to identify Slit2 as a gene significantly induced in endothelial cells by highly
metastatic cells. Slit2 is an axon guidance molecule required for the proper establishment of nervous system
connectivity. Our preliminary evidence in syngeneic models reveals that genetic inactivation of Slit2 in the
endothelial compartment significantly impairs cancer metastasis from the primary tumor site. We propose a
model whereby metastatic cells induce Slit2 in endothelial cells, which serves as a signal that promotes
migration of cancer cells within the tumor (low Slit2) towards the vasculature (high Slit2), enabling intravasation
and metastasis. This model is supported by preliminary clinical association evidence that reveals that
increased Slit2 in endothelial compartment relative to the tumoral compartment associates with higher stage
tumors that exhibit higher rates of metastatic relapse. In this application, we propose a series of
complementary approaches for rigorously confirming this surprising model and further mechanistically
dissecting it. We will modulate Slit2 signal sensing by cancer cells through genetic inactivation of endothelial or
tumoral Slit2 using cell-type specific genetic inactivation in a genetically initiated model of cancer progression.
We will employ live animal multi-photon microscopy to visualize Slit2-driven tumoral trans-endothelial migration
and intravasation. We aim to identify the tumoral receptor that senses Slit2, to use immunohistochemical
methods to investigate an association between endothelial Slit2 and human cancer progression and metastatic
relapse, and to discover the tumor-derived signal that induces endothelial Slit2. Finally, we will apply these
insights by determining if a clinically used therapeutic, which we find induces Slit2 promotes cancer metastasis.
This work has the potential for major impact on our understanding of mechanisms of cancer progression by
establishing endothelial cells as major orchestrators of metastasis. It could have important impact on human
disease given that this pathway governs progression of highly prevalent cancer types and associates with
human relapse. Moreover, the cell-type specific ribosomal profiling method we have employed could be
applied more broadly to study endless cell-types within the tumor microenvironment.

Public health relevance
Cancers such as breast cancer and melanoma kill patients by spreading and metastasizing to distant organs. We have found that cells that line blood vessels release a protein signal called SLIT2 that serves to attract tumor cells out of the primary tumor and into the blood stream, where cancer cells can then spread and metastasize. We propose to understand how SLIT2 from blood vessel cells promotes metastasis and to determine if a clinically used experimental therapeutic may activate Slit2 and enhance metastasis.